Dementia epidemiology, health service utilization and treatment costs among American Indian and Alaska Native Elders

PROJECT SUMMARY
As the US population ages, the number of people living with Alzheimer’s Disease and
related dementias (ADRD) is projected to triple by 2050. Although the life expectancy of
American Indian and Alaska Natives (AI/ANs) is much shorter than that of other US populations,
it has dramatically increased in the last few decades, with the expansion of the AI/AN elder
population expected to continue. Compared to most US populations, AI/ANs bear a
disproportionate burden of many established modifiable risk factors for dementia, such as
diabetes, obesity, and smoking. However, our knowledge about dementia in this population
remains to be severely limited. So far, only a handful of studies have examined dementia
among AI/ANs, with reliable data on the prevalence or incidence of dementia in this population
being nonexistent. Given so many gaps in our knowledge about dementia among AI/ANs, a
systematic investigation is urgently needed to identify how problematic dementia is in this
population and its impact on the Indian health system to enable more precise planning and
prioritization of resources needed to support relevant health care policy. Here, leveraging on 16
years of longitudinal data available in the Indian Health Service (IHS) Data Project, a synthesis
of existing IHS electronic health data for nearly 30% of the IHS service population (~ 640,000
AI/ANs), we propose to address 4 major knowledge gaps about dementia among AI/ANs as
guided by the following specific aims: (1) Estimate dementia prevalence, incidence, and
comorbidity rates among AI/AN elders by individual and community characteristics, such as
age, gender, location, and county level socioeconomic status; (2) Characterize the association
between dementia and potentially modifiable risk factors, such as diabetes, obesity, tobacco
use, binge drinking, traumatic brain injuries and depression; (3) Evaluate the influence of
dementia and comorbidity status on health service utilization patterns, including inpatient,
outpatient, and pharmacy services; and (4) Examine the costs of providing treatment among
AI/ANs with dementia, and factors that influence these costs such as comorbidity status. Our
proposed analyses will provide a relatively accurate and complete picture for the epidemiology
of diagnosed dementia among AI/ANs based on a large and geographically diverse sample, and
contribute to the understanding of dementia and associated health service utilization in an
extremely underserved population living in disadvantaged communities. Our findings promise to
lay groundwork for future studies on dementia to address both the needs of AI/ANs and those of
other similarly underserved populations.

Public health relevance
PROJECT NARRATIVE In order to better plan and prioritize health care resources for American Indian and Alaska Natives (AI/ANs), the aims of this project are to understand the health burden of Alzheimer’s Disease and related dementias on AI/AN elders, and their impact on the Indian health system. The work proposed here will contribute to the understanding of dementia and associated health service utilization in an extremely underserved population living in disadvantaged communities. Our findings promise to lay groundwork for future studies on dementia to address both the needs of AI/ANs and those of other similarly underserved populations.